Osteocyte CaMKII as a Critical Regulator of Bone Physiology and Anabolism

PROJECT SUMMARY
Bone responds to many signals and cues to regulate its mass and quality. During the last funding period, we identified
a pathway by which several bone anabolic agents regulate an important bone effector protein, sclerostin. This
regulation of sclerostin occurred at a surprisingly rapid time scale (minutes) in bone cells and occurred via post-
translational control of sclerostin protein destruction by the lysosome, prior to changes in gene expression. A central
integrator of these bone anabolic cues that converged on sclerostin protein destruction was the serine/threonine kinase,
CaMKII. To test the role of CaMKII in vivo in bone anabolism, we generated osteoblast-lineage (OCN-Cre)
conditional deletion mice of the two Camk2 genes expressed in the osteoblast-lineage, Camk2d and Camk2g. Prior to
these deletions, very little was known about CaMKII signaling in bone cells, and what data did exist suggested only a
relatively subtle role in osteoblast differentiation. To our surprise, these conditional knockout mice revealed a severe,
post-natal skeletal phenotype that included a large decrease in bone mass in the trabecular and cortical compartments,
spanning the appendicular and axial skeleton as well as the skull. In addition to low bone mass, these mice exhibited
skeletal fragility, markedly reduced mechanical properties, and a surprising defect in phosphate homeostasis. Given
the severity of this phenotype, we were unable to challenge this mouse with bone anabolic cues in vivo, although we
did demonstrate defective sclerostin control ex vivo in response to some bone anabolic cues. The severity of this
skeletal phenotype on this mouse is on par with the deletion of beta-catenin, a key signal integrator for bone formation,
in bone cells, and establishes CaMKII as a fundamentally important pathway controlling bone homeostasis. In this
application, our goal is to understand the unexpected role of CaMKII in osteoblast and osteocyte physiology. We will
test the hypothesis that CaMKII is a node of convergence that plays an essential role in bone physiology, including
phosphate homeostasis, the degradation of sclerostin in response to bone anabolic cues, and the post-translational
control of key effector proteins in bone. In three aims, we will examine; disentangle the molecular, cellular and
systemic contributions to the severe skeletal phenotypes of the Camk2d and Camk2g conditional knockout mice; and
resolve the role of CaMKII as a signaling node regulating sclerostin degradation for bone anabolic signals in vivo. In
total, these experiments will provide insight into the unexpectedly severe post-natal skeletal phenotype in Camk2d and
Camk2g in bone, provide insight into the major effector proteins driving this multifactorial phenotype, identify the
targets of CaMKII action in osteocytes, and answer the unresolved question as to the contribution of this pathway to
bone anabolic signals and sclerostin post-translational control.

Public health relevance
PROJECT NARRATIVE This project will examine an unexpectedly critical signaling node in osteoblast and osteocyte physiology that controls bone mass and quality as well as phosphate homeostasis. These findings will have implications on skeletal fragility, osteoporosis, and methods to optimize bone health and maybe provide new targets for regulating bone quality in health and disease.